Comparative effectiveness of breast imaging modalities: a natural experiment

DESCRIPTION (provided by applicant): We propose to conduct a comparative effectiveness study of screening and diagnostic breast imaging modalities and breast biopsies in accurately diagnosing breast cancer. Results will aid clinicians and policymakers in selecting among breast cancer detection methods while minimizing over-diagnoses and unnecessary biopsies. Several knowledge gaps in the area of breast cancer diagnosis require further study. Specifically, the evidence regarding whether digital mammography is more accurate than conventional film- screen mammography for screening certain patient subgroups is insufficient. Use of computer-aided detection to assist in interpreting images is gaining widespread use, but the evidence for improved accuracy with this technology is incomplete. There are also knowledge gaps in effectiveness for diagnostic ultrasound and magnetic resonance imaging. We propose a natural experiment to examine the comparative effectiveness of different imaging modalities and breast biopsy procedures in diagnosing breast cancer. We are partnering with Advocate Health Care (AHC), the largest integrated not-for-profit health care delivery system in the metropolitan Chicago region and one of the top 10 of its kind in the nation. Advocate patients are urban and suburban and have diverse racial/ethnic and socioeconomic backgrounds, and they reflect variation in breast cancer risk in the general population. The Illinois State Cancer Registry (ISCR) is one of the most highly recognized population-based cancer registries in the nation. After linking data from the AHC radiology database for years 2001 through 2011 with incident breast cancer cases from ISCR through 2012, we will model accuracy measures for different imaging and biopsy procedures stratified by important clinical characteristics. We will also evaluate the accuracy of imaging and biopsy procedures in detecting more aggressive breast cancer subtypes and more difficult to detect histologies. All models will adjust finely for measured facility, radiologist and patient characteristics, and calendar time. We will also examine how changes over time in clinical practices and introduction of new technologies may have affected imaging and biopsy accuracy. The sample size for this proposed study would far exceed any prior study on the topic of screening and diagnostic imaging accuracy in breast cancer. This is a highly innovative natural experiment that proposes to examine relations across the continuum of breast cancer screening, diagnostic imaging, and breast biopsy as practiced in a real-world setting. Given the large sample size and the proposed collection of detailed information on potential confounders, we believe that our study will make a substantial contribution to the literature and to future clinical, administrative, and policy decision-making.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this study is to examine the comparative effectiveness of breast imaging and biopsy procedures in ruling in or ruling out a breast cancer diagnosis. This study will create generalizeable knowledge that can be used by clinicians and policymakers to maximize breast cancer detection while minimizing over-diagnoses and unnecessary biopsies. Results of this study will allow clinicians (including primary care physicians, radiologists, and breast health specialists), managed care organizations, health insurance companies, and government payers (including CMS and state Medicaid agencies) to make more informed decisions regarding the use of diagnostic imaging and biopsy procedures for specific patient subgroups. 7. Project Narrative The goal of this study is to examine the comparative effectiveness of breast imaging and biopsy procedures in ruling in or ruling out a breast cancer diagnosis. This study will create generalizeable knowledge that can be used by clinicians and policymakers to maximize breast cancer detection while minimizing over-diagnoses and unnecessary biopsies. Results of this study will allow clinicians (including primary care physicians, radiologists, and breast health specialists), managed care organizations, health insurance companies, and government payers (including CMS and state Medicaid agencies) to make more informed decisions regarding the use of diagnostic imaging and biopsy procedures for specific patient subgroups. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The first three specific aims are to estimate the comparative effectiveness of screening imaging, diagnostic imaging and diagnostic biopsy procedures. Comparative effectiveness estimates will be made for clinically relevant subgroups while adjusting for differences in lesion, patient, radiologist and facility characteristics, as well as prior screening interval. The main performance characteristic of interest will be the area under the receiver operating characteristic [8] curve, but we will also estimate the ability of procedures to rule in a breast cancer (sensitivity and positive predictive value) and to rule out a breast cancer (specificity and negative predictive value). We will also use data on breast cancer histology and aggressiveness from ISCR to determine the accuracy of imaging and biopsy modalities in detecting more aggressive breast cancer subtypes and more difficult to detect histologies. Specific aim 1 is to examine the comparative effectiveness of screening with digital mammography vs. film screen mammography. We hypothesize that digital mammography will be associated with a higher recall rate, a greater proportion of minimal cancers and a higher breast cancer detection rate compared with film screen mammography. We also hypothesize that digital mammography will be associated with greater sensitivity and a greater area under the ROC curve for younger women, premenopausal women, and women with denser breasts. Exploratory analyses will examine how performance measures for digital and film screen mammography vary according to diagnostic prompt, first-degree family history of breast cancer, and time since last screening. Specific aim 2 is to examine the comparative effectiveness of diagnostic imaging with film screen mammography, digital mammography, ultrasound and breast magnetic resonance imaging (MRI). We hypothesize that breast MRI will perform better than other procedures and digital mammography will perform better than film screen-mammography, especially for younger women, premenopausal women, and women with denser breasts. Exploratory analyses will examine how performance measures for diagnostic imaging procedures vary according to diagnostic prompt, first-degree family history of breast cancer, lesion characteristics at screening, and other relevant clinical subgroups. Specific aim 3 is to examine the comparative effectiveness of diagnostic breast biopsy procedures. For each biopsy procedure (image-guided needle biopsies including stereotactic, ultrasound and MRI-guided; stereotactic vacuum-assisted biopsy and surgical biopsy) we will estimate the rate of histological underestimation as well as the miss rate which is defined as the probability of cancer following a negative result. Exploratory analyses will examine how performance measures for diagnostic biopsy procedures vary according to diagnostic prompt, lesion characteristics at screening, and other relevant clinical subgroups. Specific aim 4 is to describe learning curves associated with the introduction of new technologies in this health system. We will examine how performance measures for screening and diagnostic procedures changed with increasing calendar time as well as with increasing time since the introduction of the new technology at each clinic. New technologies to be examined include computer-aided detection and digital mammography. Of particular interest is whether changes in performance over time are consistent with a learning curve.